Pacific Symposium on Biocomputing

Project Summary/Abstract
The Pacific Symposium on Biocomputing (PSB) is multidisciplinary conference covering current
research in the theory and practice of computational methods as applied to significant biological
problems. PSB 2025 – 2030 will be the 30th to 35th meeting of this series.
Each February, individuals from the scientific community propose sessions and workshops for
the PSB meeting to be held the following January. In the face of stiff competition, 5 to 6
sessions and 4 to 6 workshops are chosen. These sessions and workshops are often organized
by junior scientists who are developing new research areas. Thus, PSB provides early
opportunities for serious examination of emerging research areas. PSB also provides junior
scientists the opportunity to gain a significant career boost by this activity. Our goals are for
sessions to cover emerging areas and for workshops to bring attention to very newest
developments. This bottom-up, crowdsourcing approach has worked well to reveal the newest
developments in the diverse topics in biocomputing.
At the meeting, session organizers present a short introduction to the session usually followed
by a high-profile speaker, typically a biologist, who provides an overview highlighting the
importance of the research area. Next, 4 to 10 oral presentations (based on the number of
accepted papers) are delivered. Submitted papers are rigorously peer-reviewed, with typically ≤
30% being accepted. These peer-reviewed papers are published in the annual PSB
proceedings (viewed as a journal by PubMed), are open access, and indexed by PubMed.
Additionally, the meeting has 4 to 6 workshops, two keynote speakers (scientific and ELSI), four
invited speakers, and a continuously running poster session. The poster session is one aspect
of the conference that provides junior scientists with opportunities to network with prominent
scientists in the field. PSB has historically been held in Hawaii and the conference venue
creates many opportunities for organic networking/collaborative discussions to arise. PSB has
continually improved from participant feedback; specific examples of this improvement will be
provided.
The PSB meeting is highly regarded. PSB continues to foster the development of computational
biology and bioinformatics by providing important, critical exposure to emerging areas and thus
deserves continued support.

Public health relevance
Narrative Improving human health will require improved understanding of human DNA, which has about 3 billion units that code for more than 20,000 different proteins (with many of these proteins existing in multiple forms) and for an undetermined number of regulatory molecules. Dealing with all of these entities and their interactions requires extensive use of computer algorithms, particularly as we move to an era of precision health. Exchanging information about the development and optimal use of these computational biology and bioinformatics algorithms is the focus of the Pacific Symposium on Biocomputing (PSB), which is one of the more significant scientific meetings on this topic.